Administrative Core

The SARS-CoV-2 pandemic represents an exceptional public health crisis highlighting the need for
better understanding of the mechanisms controlling broadly protective immune responses and generating
vaccine candidates able to elicit such responses. The program project entitled “Programming Long-lasting
Immunity to Coronaviruses (PLUTO)” proposes a comprehensive research plan towards designing pan-
sarbecovirus and pan-betacoronavirus vaccines with broad protection by applying in-depth B cell
characterization in the context of coronavirus immune histories imprinted by successive vaccinations
and/or infections. Two complementary research projects will establish correlates of robust, durable
and protective coronavirus humoral immunity (Project 1) as well as design and test efficacy of viral
variant-proof pan-sarbecovirus and pan-betacoronavirus vaccines. The Administrative Core led by one of
the two Principal Investigators, Dr. Viviana Simon, will function as a coordinating hub of the program
providing a strong overall administrative infrastructure. The proposed activities and services of the
Administrative Core are to provide overall management and program coordination, to facilitate
communication within the program, to monitor progress within the projects and to prioritize, allocate, and
manage resources. It will also support cooperation between the Research Projects and Service Cores by
putting in place transfer agreements, data management plans and conflict resolution procedures. The
Antibody Core will develop a large panel of recombinant monoclonal antibodies (mAbs) against coronavirus
spike proteins to aid in defining specificity of immune responses elicited by coronavirus infection and/or
vaccination in humans and animal models. The Animal Model Core will provide a central resource with
approvals, facilities, and expertise to assess efficacy of broadly cross-reactive coronavirus antibodies and
vaccines in robust pre-clinical models against a spectrum of coronaviruses, including Select Agents. A
multidisciplinary team of scientists from five institutions who have an outstanding track record of working
collaboratively will conduct the proposed studies. The Research Projects will collaborate across
projects and with the Antibody and Animal Model Cores, coordinated by the Administrative
Core. The integrated and synergistic activities across Projects and Cores will drive successful
completion of the program project's ambitious research agenda, enabling achievement of the long-term
PLUTO goal of developing variant-proof pan-sarbecovirus and pan-betacoronavirus vaccines. These
findings will contribute to curbing the current SARS-CoV-2 pandemic and mitigate the risk of future
pandemics with coronaviruses.